Mixed Lineage Kinase 2 (MLK2) and vascular homeostasis

Project Summary
Cardiovascular diseases are among the nation's leading causes of death and disability, with an estimated cost
of more than $351 billion in the USA. Ischemia-induced angiogenesis plays an important role in the recovery of
many vascular diseases. The endothelium plays an even more important role in vascular homeostasis as it
regulates vascular tone, thrombosis, leukocyte trafficking, metabolism, and angiogenesis. Maintaining normal
endothelial function requires balancing numerous physiological and pathophysiological stresses such as shear,
hypoxia, and inflammation. Among the pathways mediating cellular stress, responses are the stress-activated
members of the MAP kinase (MAPK) superfamily, which includes c-Jun N-terminal kinase (JNK) and p38 MAPK.
JNK protein plays an important role in collateral artery formation during development. Recently, we have shown
that neural JNK3 plays a significant role in blood flow recovery after hindlimb ischemia. In probing upstream
components of the MAPK signaling cascade (MAP2K and MAP3K), we found that Mixed Lineage Kinase 2
(MLK2), a MAP3K and upstream regulator of MAPK, is expressed in endothelium and required for normal
postnatal endothelial function. In fact, MLK2-deficient endothelial cells exhibit profound defects in angiogenesis
as well as endothelial proliferation and migration. MLK2 also plays a significant role in VEGF signaling, which is
required for proper endothelium function. RNA-seq data indicates that MLK2-deficient endothelial cells exhibit
both basal and VEGF- induced upregulation of a broadly conserved microRNA, miR-146a, that has previously
been linked to inflammation. Mimics of this miR-146a miRNA administered to wild-type endothelial cells
recapitulate a broad spectrum of the MLK2-deficient phenotype, including defects in proliferation and VEGF
signaling. Using these strategies, we should be able to develop a clear picture of how MLK2 influences
endothelial function and vascular homeostasis. These data will be important as MLK inhibitors are being tested
in the cancer field since very little data is understood regarding their cardiovascular consequences. Moreover,
how Mlk2 influences the vasculature is a large gap in knowledge that we will address.

Public health relevance
Cardiovascular diseases are the number one cause of morbidity worldwide, and endothelium plays an important role in cardiovascular health. This project investigates a pathway known as Mixed Lineage Kinase 2 and how it impacts the endothelium and is based on our findings that Mixed Lineage Kinase 2 is needed for normal endothelial function and control signals needed for new blood vessel formation.